P30-Core Grant for Vision Research Core A

Summary SBI Core A
The Structural Biology and Imaging (SBI) Core enhances vision research of AVRC
members by assisting them in determining the relationship between normal and
abnormal tissue structure in eye diseases, disease models and after experimental
treatments. This SBI Core provides facilities and services for AVRC members to
determine structural changes and how they relate to function through state of the art
histology, electron microscopy, confocal scanning laser microscopy and experimental
animal surgery imaging. The SBI Core also supports obtaining structural data and
interpretation of this data for new initiatives of AVRC members with an emphasis on
retinal function, retinal degeneration/injury, RPE morphometry, ocular oncology, and
gene/drug delivery. The SBI Core enables localization of proteins involved with control of
retinal function in health and disease; imaging of tissue changes in retinal and optic
nerve degenerations; correlation of RPE morphometric changes with genotype and
function; development of imaging techniques for primary and metastatic ocular tumors,
including tissue correlations with MRI contrast agents and tele-imaging; and studying
ocular tissue changes relative to gene and drug delivery to the posterior ocular
compartment. This core facilities capture and porting of high resolution large images
from devices to other Core modules. This Core helps unskilled or neophyte NEI R01
awardees to understand and use university cores for super-resolution microscopy
approaches. This Core supports image capture and processing that would normally be
beyond the capabilities that could be proposed under a normal R01 mechanism.

Public health relevance
Narrative sections are not allowed for the Admin, and Cores A, B, and C modules according to PA-20-051.